Tissue Core

PROJECT SUMMARY
TISSUE CORE
The Tissue Core (TC) serves as the central biorepository for Moffitt Cancer Center (Moffitt). Opened in 1992,
the overall goal of TC is to collect, process, store, and release high-quality, well-annotated biospecimens in
support of basic, clinical, population, quantitative and translational research. TC provides a wide variety of
services including fresh frozen tissue collection, histology, immunohistochemistry, nucleic acid extraction,
generation of tissue microarrays, and archived biospecimen release. Further, TC consults on and implements
project-specific SOPs, including study design and collection strategies to optimize specimen handling. TC offers
75 distinct services that meet or exceed NCI best practice recommendations and CAP Biorepository
Accreditation standards, which ensures rigor and reproducibility in sample collection and processing that is
validated through standardization, documentation, and quality management. TC activities towards its goals are
organized into three Specific Aims:
Aim 1: To serve as the centralized Moffitt biobanking resource for the collection, processing, and storage of
biospecimens.
Aim 2: To facilitate and ensure access to high-quality biospecimens and state-of-the-science services through
implementation of biorepository best practices.
Aim 3: To enrich Member research through streamlined utilization, biospecimen education and training that
ensures high-quality outcomes.
Over the previous funding cycle, TC services continued to improve efficiency, communication, and turn-around
times and the TC addressed the evolving complexity of specimen collection to support novel projects. This
yielded three new service sections: Biospecimen Processing Services, TC Total Cancer Care Section to support
Moffitt’s institutionally funded biobanking protocol, and TC Clinical Trial Biospecimen Services, which provides
dedicated support for clinical trials. Further, TC collaborates as an active site for NIH consortium projects such
as the Clinical Proteomic Tumor Analysis Consortium that provides biospecimen collection, processing,
dissemination and data annotation via Moffitt’s Total Cancer Care institutional biobanking protocol. TC also
serves as the Central Lab and Biorepository for NHLBI’s National Myelodysplastic Syndrome Natural History
Study. Over the last five years, TC contributed to 188 publications (37 high impact) and 154 grants. In FY20
alone, TC supported 120 Members (69% peer review funded) in all five Programs (CBE 18 %, CE 18 %, MM 31
%, HOB 5%, IO 28%). Collectively, TC supported 350 protocols during FY20. Of those protocols, 219 were
clinical trials, increasing from 93 in FY2019 and 64 in FY2018.